Computational Modeling and Analysis Core

Program Director/Principal Investigator (Last, First, Middle): Michael A. Webster
Project Summary
Computational Modeling and Analysis Core
In Phase III, the Computational Modeling and Analysis (CMA) Core will provide COBRE investigators with
expanded computational services by establishing formal structures and pipelines into a cohesive unit of
operation with four main operational components (high-performance computing, CPU-intensive computing,
machine learning infrastructure, design to development pipelines). In particular, the Core will offer investigators
specialized expertise in artificial intelligence (AI) and computational modeling relevant to neuroscience
experiments, including analysis and interpretation of various physiological and functional measurements,
design and development of deep learning models for medical and behavioral sciences, deployment of
accelerated AI frameworks on high-performance computing platforms, and sophisticated statistical analysis for
a wide variety of tasks. The core will be directed by a research computing expert, Dr. Alireza Tavakkoli, who is
an associate professor of computer science and engineering with expertise in AI, machine learning, computer
vision, high-performance computing, and interdisciplinary computing. During Phase III, the core will focus on
establishing a streamlined and sustainable model of operation through the following aims: 1) to expand and
enhance computational capabilities, services, and resources; 2) to provide access, training, education and
assistance in statistical analysis and computational modeling; 3) to establish a sustainable core facility within a
distributed Computational Modeling Unit and infrastructure to support it. The Computational Modeling and
Analysis core will provide resources and services essential to ensure competitiveness of UNR and COBRE
investigators by utilizing novel and sophisticated AI-enabled computational modeling and interpretation as well
as statistical analysis and data analytics support for studies focused on the neurosciences.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page

Public health relevance
Project Narrative Computational Modeling and Analysis (CMA) Core The Computational Modeling and Analysis Core will provide state-of-the-art AI and deep learning frameworks as well as advanced statistical design and analysis support for projects focused on the neurosciences. These services will meet the critical recognized need for computational resources to increase scientific rigor and leverage modern tools and statistical learning for big data.